Super-Resolution Deep Learning Framework for Enhanced ADPKD Monitoring via Multi-Sequence Longitudinal MRI

ABSTRACT
Autosomal Dominant Polycystic Kidney Disease (ADPKD) is a prevalent genetic disorder affecting millions
worldwide, characterized by cyst formation primarily within the kidneys, leading to organ enlargement and
deteriorating function. This condition often extends to the liver, posing significant clinical challenges. Traditional
qualitative analysis methods are insufficient for accurate disease assessment, prognosis, and treatment
guidance. Deep Learning (DL) models have shown promise in estimating Total Kidney Volume (TKV) from MRI
images but face limitations in detecting early-stage disease with small cysts. This study aims to transform
qualitative analysis into quantitative assessment through multi-class cyst segmentation in ADPKD. Aim 1 focuses
on developing a super-resolution DL model to generate high-resolution 3D MR volumes. Multiple imaging planes
(axial, coronal, sagittal) will be incorporated to enhance 3D resolution for precise biomarker calculation.
Additionally, a multi-class multi-sequence DL framework will be developed for ADPKD severity assessment,
which involves creating segmentation and object detection models for different cyst classes, including simple,
hemorrhagic, and exophytic cysts within the kidney, liver, and pancreas. Aim 2 aims to build a prognostic model
for predicting estimated glomerular filtration rate (eGFR) decline and disease progression. This will involve
developing an accurate predictive model based on biomarkers extracted from high-resolution MR images, with
a particular focus on cyst class information, especially hemorrhagic cysts, to improve eGFR decline forecasts
and dialysis potential predictions. Aim 3 integrates patients' longitudinal data to quantify the impact of temporal
dynamics on disease progression over the next 10 years, by developing a multimodal predictive model that
incorporates patients' prior MRI scans and historical data. This study aims to utilize DL models to shift from
qualitative to quantitative assessment of ADPKD using multi-sequence high-resolution MR images, enabling
precise measurement of cyst attributes, and advancing our understanding of disease progression and treatment
response for better patient outcomes.

Public health relevance
PROJECT NARRATIVE This project seeks to revolutionize the assessment and management of Autosomal Dominant Polycystic Kidney Disease (ADPKD), a widespread genetic disorder with significant clinical impact. By developing a high-resolution multi-sequence Deep Learning framework, we aim to enable precise and quantitative measurement of cyst attributes across multiple organs, advancing our understanding of disease severity and progression. By incorporating high-resolution 3D imaging, achieved through multi-plane super-resolution technique, and cyst class information, our prognostic model aims to provide more accurate predictions of disease outcome and facilitate early intervention, ultimately enhancing patient care and outcomes in the realm of ADPKD.